IL-6 and IL-6R genetic polymorphisms in immune-related adverse events caused by cancer immunotherapy

SUMMARY
The achievements obtained with different types of cancer immunotherapy are clear, with durable long-term
survival in some cases. The most frequently used immunotherapeutic approach is the treatment with
immunocheckpoint inhibitors (ICI). However, the major limitation of these immunotherapies is the relative high
frequency of long-lasting immuno-related adverse events (irAEs) associated with the treatments. irAEs triggered
by ICI can affect most any tissue. Thus, given the increasing burden of irAEs, determining a) the mechanisms
that drive the irAEs, b) those patients who are at a higher risk to develop irAEs, and c) novel strategies to
minimize irAEs while sustaining the ICI anti-tumor efficacy are unmet needs. The irAEs caused with ICI
treatments are mainly due to an overresponse of CD4 and CD8 cells, and T cell-produced cytokines are a major
mediator of irAEs. Until recently, minimal attention was given to IL-6 as a mediator of the irAEs from ICI therapy,
despite the well-established role of IL-6 in the pathogenesis of a number of inflammatory diseases. This is in part
due to the fact that IL-6 is considered a cytokine produced by the innate immune system. We have recently
shown that human CD4 cells (but not mouse CD4 cells) from healthy volunteers produce high levels of IL-6
quickly after activation. The levels of IL-6 produced by human CD4 cells after activation are heterogenous among
healthy volunteers, suggesting a potential genetic influence. Although IL-6R expression is restricted to
leukocytes and hepatocytes, IL-6 can also trigger signals in cells that do not express IL-6R (e.g. endothelial cells,
neurons, cardiomyocytes) and cause pathology when soluble IL-6R (sIL-6R) is present, binds to IL-6 and
associates with ubiquitously expressed gp130. We have shown that human CD4 cells produce high levels of sIL-
6R upon activation.
There is a high-frequency polymorphism in the promoter of human IL-6 gene (-174G/C, rs1800795) that
can affect the production of IL-6. Similarly, a polymorphism (rs2228145) in the coding region of the IL-6R gene
can lead to enhanced levels of sIL-6R. We propose that the IL-6 and/or sIL-6R produced by activated CD4 cells
after treatment of cancer patients with ICI are major mediators of the irAE caused by this therapy, and that the
genetic polymorphisms in IL-6 and/or IL-6R genes could determine the risk of patients to develop irAE. We will
investigate: 1) the effect of genetic polymorphisms on the production of IL-6 and sIL-6R by human CD4 cells
from healthy volunteers; 2) whether polymorphisms in IL-6 and/or IL-6R genes are associated with the
development of irAE in ICI-treated cancer patients.

Public health relevance
PROJECT NARRATIVE Immunecheckpoint inhibitors are the most common type of immunotherapy used for treatment of a large variety of cancers and can lead to long-term remissions in responder patients by boosting their anti-tumor T cell immune response, but it is becoming clear that they can also cause long-term adverse effects in a relative high frequency due to an unleashed systemic immune response. There is a major need to identify who is at a higher risk to develop these immune related adverse events (irAE) and how to manage these effects as part of personalized medicine. We propose to examine genetic polymorphisms in the IL-6 and IL-6R genes that can make CD4 T cells from cancer patients to produce higher levels of this cytokine and to cause damage of different tissues through their response to IL-6.